NARCH XII-Admin CORE

Calac-Core CA-NARCH XII Project Summary
PROJECT SUMMARY
The overall goals of the CA-NARCH Administrative Core are to support the research efforts of
the NARCH XII projects and to provide critical ongoing community-based participatory tribal
direction. The administrative structure of the CA-NARCH has evolved through funding from
NARCH III, V, VII, and X and consists of the Indian Health Council Executive Team, Scientific
Advisory Board, CA-NARCH Tribal IRB, and a Research and Student Development Director.
The specific aims of the CA-NARCH Administrative Core are:
Specific Aim 1. To provide administrative, fiscal, and management direction and oversight to
the CA-NARCH XII research projects.
Specific Aim 2. To coordinate communication among the proposed projects and between the
proposed projects and the tribal communities.
Specific Aim 3. To provide guidance to proposed projects in evaluation planning.
Specific Aim 4. To increase the institutional profile of the CA-NARCH through representation
on Community Advisory Boards for local academic or research institutions.
The above specific aims will support the efforts of the NARCH initiative and CA-NARCH mission
of conducting highly relevant, American Indian/Alaskan Native (AI/AN) community-based
research. This work serves as a model for tribal nations and academic organizations doing
collaborative research.

Public health relevance
Calac-CORE CA-NARCH XII Project Narrative Project Narrative The overall goals of the CA-NARCH Administrative Core are to support the research efforts of the NARCH XII projects and to provide critical ongoing community-based participatory tribal direction. The CA-NARCH Administrative Core aims to 1) provide administrative, fiscal, and management direction and oversight to the CA-NARCH XII research projects; 2) coordinate communication among the proposed projects and between the proposed projects and the tribal communities; 3) To provide guidance to proposed projects in evaluation planning; and 4) increase the institutional profile of the CA-NARCH through representation on Community Advisory Boards for local academic or research institutions.